Oral and Craniofacial Sciences Health Research Training

PROJECT SUMMARY/ ABSTRACT:
The goal of the UCSF Oral and Craniofacial Sciences (OCS) training program is to provide multidisciplinary
education and training to address questions of biological relevance to dental, oral and craniofacial science, and
clinical care. We train a diverse group of students from a broad range of backgrounds. Our program faculty are
well trained in skills related to mentoring and support of diversity, equity and inclusion in all education and
training activities. The trainees supported by this training grant, include those pursuing DDS/PhD, PhD, and
postdoctoral fellowships. PhD program components include rigorous didactic courses and hands-on training
courses; lab rotations in three different labs; oral presentations of scientific information and hypotheses
defense via tutorial training with faculty in a journal club setting; an intensive oral qualifying exam; individual
thesis research and finally; a dissertation seminar. DDS/PhD trainees combine this training with a dental
school education. Postdoctoral fellows focus on identifying and developing their own unique research
directions. Integrated throughout this training program, from the first day to the last, are activities that train and
encourage trainees to :i) develop skills in responsible conduct of research (RCR), rigor & reproducibility and
chemical and biological safety; ii) openly receive and give feedback through evaluation and assessment tools; iii)
foster career interests, including use of Individual Development Plans (IDPs); iv) enhance written and oral
communication skills; (v) celebrate diversity and a sense of community and vi) gain training in critical analysis via
journal clubs, seminars and minicourses. The research in the OCS program is highly inter-disciplinary and includes
research in tissue engineering, regenerative medicine, cell and cancer biology, biomaterials and
bioengineering, craniofacial and skeletal biology, microbiome/microbiology, and clinical and translational
research. To enact this training program, the OCS program is not associated with a specific department; rather, we
bring together faculty from throughout UCSF’s world-class research enterprise, currently representing ten different
academic departments in the Schools of Dentistry, Medicine, and Pharmacy. Oversight of the OCS program is
maintained by the OCS Steering Committee, along with an engaged Dean of the UCSF School of Dentistry and
UCSF Graduate School, and an expert external advisory committee. Member faculty are rigorously and holistically
evaluated by the OCS Steering Committee for excellence in research, mentoring and commitment to diversity, and
these faculty are required to complete annual mentor training. Interdisciplinary research training is carried out
within an intellectually integrated and well-equipped collection of member labs, and a uniquely collaborative,
interactive and communicative research environment. Our graduates are highly sought-after in academia,
industry and beyond, because of their training, creativity and passion for inter-disciplinary science.

Public health relevance
PROJECT NARRATIVE The UCSF Oral and Craniofacial Sciences training program educates diverse students to apply scientific approaches to solve the most challenging problems in dental, oral and craniofacial health. The goal of this training grant is to provide the financial resources for education and training of DDS/PhD, PhD and postdoctoral fellows to become influential leaders in academic and industrial biomedical research, and other fields related to dental, oral and craniofacial science.